Effectiveness and Cost-Effectiveness of Peer Mentors in Reducing Hospital Use

DESCRIPTION (provided by applicant): The last decade has seen a dramatic increase in the development of peer-provided services for adults with serious mental illnesses. The empirical evidence supporting such services lags behind their rapid proliferation, however. Reviews have shown that people with histories of mental illness can provide certain conventional services at least as effectively as non-peers, but have found little evidence for their superiority on a wide range of outcomes. Very few of these studies evaluated peers providing peer support as its own service, though, and even fewer evaluated those aspects of peer support which are thought to be unique to this form of service delivery. The proposed study seeks to be one of the first to use rigorous methods to evaluate the effectiveness peer support as compared to other services offered with the same frequency and intensity by both peers and non-peers. Specifically, the proposed study aims to: 1) evaluate the effectiveness of peer support, as compared to usual care and to an equivalent amount of support offered by peer case managers and non-peer recovery mentors; 2) evaluate the influence of patient diagnosis as a potential moderating variable in determining the effectiveness of peer support; 3) evaluate the cost-effectiveness of peer support; and 4) integrate and test a theoretical model of the active ingredients of peer support. Based on the literature on peer support and the research team's own work in this area, these ingredients are hypothesized to be an instillation of hope through positive self-disclosure; role modeling of self-care and exploring new ways of using experiential knowledge; and a trusting relationship characterized by empathy linked with conditional regard. To achieve these aims, we propose to conduct a mixed-methods, qualitative/quantitative study. The qualitative component will involve interviews with participants both early and late in the study, with the aims being to refine the theoretical model and measures (early) and inform and illustrate the quantitative data analysis (later). For the quantitative component, we propose a randomized, controlled design involving a total of 320 adults with serious mental illnesses and histories of multiple hospitalizations who will be randomly assigned to one of the following conditions: 1) usual care; 2) usual care plus the services of a peer case manager; 3) usual care plus the services of a non-peer recovery mentor; and 4) usual care plus the services of a peer recovery mentor. Fidelity measures will be used to ensure the integrity of the 4 conditions. Data will be collected during the index hospitalization and at 3 and 9 months after discharge. Outcomes will include hospitalization events and days, symptoms, clinical and functional status, community inclusion, substance use, and perceived recovery and quality of life. Changes in demoralization, hope, self-efficacy, self-care, the relationship between participant and case manager or mentor, and social support will also be assessed to test the theoretical model informing the proposed study. Diagnostic data will be collected to determine its influence on effectiveness and cost data will be collected to enable calculations of the cost-effectiveness of peer support. PUBLIC HEALTH RELEVANCE: The proposed study is one of the first attempts at a rigorously controlled study of peer support, as most studies of peer-provided services to date have not distinguished between the person's identity as a peer, his or her role as a provider of a certain kind of service, and the degree to which the person uses his or her own experiences in the work. The proposed study is therefore unique in that it: 1) includes 2 additional comparison conditions in which participants will receive an equal frequency and duration of generic support from either a peer case manager or a non-peer recovery mentor; 2) investigates the possibility that patient diagnosis may moderate the effectiveness of peer support; 3) includes a cost-effectiveness component; and 4) integrates and empirically tests a theoretical model of the active ingredients of peer support in order to tease apart those components of this new form of service that are potentially the most unique and perhaps also the most effective in helping people to live with serious mental illness. As general mental health funds are dwindling, this study promises to be extremely useful in informing future policy and programmatic decisions related to the promotion of evidence-based practices in the care of individuals with serious mental illnesses.

Public health relevance
7. Project Narrative The proposed study is one of the first attempts at a rigorously controlled study of peer support, as most studies of peer-provided services to date have not distinguished between the person's identity as a peer, his or her role as a provider of a certain kind of service, and the degree to which the person uses his or her own experiences in the work. The proposed study is therefore unique in that it: 1) includes 2 additional comparison conditions in which participants will receive an equal frequency and duration of generic support from either a peer case manager or a non-peer recovery mentor; 2) investigates the possibility that patient diagnosis may moderate the effectiveness of peer support; 3) includes a cost-effectiveness component; and 4) integrates and empirically tests a theoretical model of the active ingredients of peer support in order to tease apart those components of this new form of service that are potentially the most unique and perhaps also the most effective in helping people to live with serious mental illness. As general mental health funds are dwindling, this study promises to be extremely useful in informing future policy and programmatic decisions related to the promotion of evidence-based practices in the care of individuals with serious mental illnesses.